Comorbidity in traumatic brain injury and risk of all-cause mortality, functional and financial burden: a decade-long population based cohort study

FUNDING OPPORTUNITY: Secondary analysis of existing databases in traumatic brain injury to explore outcomes relevant to medical rehabilitation (R21); RFA-HD-16-001 PI: COLANTONIO A PROJECT SUMMARY: Comorbidity is prevalent after traumatic brain injury (TBI) and across the spectrum of injury severity. It can be present at the time of injury, arise early after injury, or during hospitalization or inpatient rehabilitation. Long-term follow-up studies of individuals who had endured a TBI report that patients have numerous co-existing disorders. Nevertheless, our comprehension of the when (i.e., pre- or post-injury presentation), how (i.e., how the conditions affect the injured individual and their subsequent demand for health care services) and which (i.e., which comorbid conditions cause the greatest burden), with respect to excessive use of resources, functional outcomes, and all-cause mortality, remain unanswered. Larger population- based studies are necessary to address these research gaps. The proposed retrospective cohort study will utilize linked data of all patients with TBI diagnostic codes, derived from emergency departments (National Ambulatory Care Reporting System), acute care (Discharge Abstract Database), inpatient rehabilitation (National Rehabilitation System), community services and long-term care (Home Care Database), continuing care (Continuing Care Reporting System), and prescription data (Ontario Health Insurance Plan Claims Database) over a 10 year period. At least 35,000 acute care cases over a 10 year period form the basis of the longitudinal analysis. These data have undergone quality assessments and linkage by the Institute for Clinical Evaluation Sciences, a non-profit independent organization that carries out research to improve the effectiveness of health care services in Ontario, Canada. We hypothesize that acutely derived variables (i.e., age, intracranial injury, injury mechanism, injury severity, length of stay) — currently the focus of most research efforts in TBI and comorbidity — are not by themselves sufficient to accurately predict resource consumption, all-cause mortality, and functional outcomes in individuals with TBI, stratified by age and sex. We further hypothesize that an expanded set of factors and factor clusters including patient demographic, certain clinical (i.e., comorbid) disorders and social indices, will provide greater accuracy in predicting resource consumption, all-cause mortality and functional outcomes of TBI, and these clusters will be subject to change over time. This study of comorbidity in patients with TBI may lead to uncovering challenging multifaceted problems (i.e., frailty and patient complexity) that are currently not well defined but generally considered to be closely related to the presence of multiple comorbid disorders. October 2015

Public health relevance
FUNDING OPPORTUNITY: Secondary analysis of existing databases in traumatic brain injury to explore outcomes relevant to medical rehabilitation (R21); RFA-HD-16-001 PI: COLANTONIO A PROJECT NARRATIVE: Because the brain regulates all voluntary and involuntary functions, brain injury can affect all organs and body systems and cause and/or expedite multiple disease progression. Recognizing this, recent initiatives in traumatic brain injury (TBI) care have highlighted the complexity of its medical management and recommend that it include an assessment of any co-existing (comorbid) medical disorders. However, there remains a need for an advanced understanding of when the condition(s) occurred (i.e., pre- or post-injury), how the conditions affect the patient with TBI, and which comorbid conditions cause the greatest burden with respect to excessive use of resources in TBI, functional outcomes, and all-cause mortality. The study team, with experience in traumatic brain injury research, rehabilitation science, neuroscience, biostatistics, and large database analysis, proposes a retrospective cohort study of comorbidity in TBI that is population-based, scalable and feasible. October 2015